Administrative Supplements to Existing NIH Grants and Cooperative Agreements (administrative supplement to 5K23HL171951, Adaptation and pilot testing of a family-centered intervention to improve long-

This is an application for a five-year mentored patient-oriented research career development award (K23). The
overall goals are to 1) adapt and pilot test a family-centered intervention designed to improve long-term
outcomes for survivors of acute respiratory failure, and 2) educate and mentor the candidate clinician
investigator while she transitions to independence. The candidate is an assistant professor in the Division of
Pulmonary Diseases and Critical Care Medicine at the University of North Carolina Chapel Hill. She recently
completed a three-year award period on UNC’s KL2 during which she generated key preliminary data to inform
this proposal. The members of her mentoring team have an established record of mentoring junior faculty, high
research productivity, and substantial peer-reviewed support. Her mentoring and advisory team includes
experts in ICU patient and family caregiver outcomes (Carson), palliative care (Hanson), communication and
decision-making support in the ICU and after ICU discharge (Cox), support of patients and caregivers during
care transitions (Toles), and psychiatry (Gaines), clinical psychology (Trivedi) as well as a dedicated
biostatistician (Lin). The research and training environment at the University of North Carolina Chapel Hill is
strong and well established. UNC is a national leader in research, with over $1 billion in extramural support in
fiscal year 2020. UNC-Chapel Hill faculty researchers receive more than $528 million in NIH research funding
annually, and UNC is first in the nation for federally funded social and behavioral science research and
development. The candidate’s career development objectives are as follows: 1) To gain skills and experience in
the development and adaptation of behavioral health interventions; 2) To obtain training and experience in
conducting randomized clinical trials; and 3) To gain proficiency in best practices for virtual participant
engagement and intervention delivery. To achieve these goals, the candidate will: 1) participate in advanced,
graduate level coursework; 2) gain experiential learning as a co-investigator on a multi-site randomized clinical
trial of family support intervention; 3) attend The North Carolina Translational & Clinical Sciences Principal
Investigator Development Series and join the R-Writing Group; and 4) conduct mentor guided research. The
specific aims of the research project are: 1) To adapt the Self-Management Using Collaborative Coping
Enhancement in Diseases (SUCCEED) intervention, a family-centered coping skills intervention for seriously ill
patients and their family caregivers, for use in acute respiratory failure (end product: SUCCEED-ICU); and 2)
To test the feasibility, acceptability, and preliminary efficacy of SUCCEED-ICU in a pilot randomized trial. The
support and mentorship provided by a K23 is critical to achieve the candidate’s goal of transitioning to an
independent clinician investigator in the field of improving long-term outcomes for patients who have
experienced acute respiratory failure.

Public health relevance
Project Narrative Over 1.5 million patients are admitted to an intensive care unit (ICU) with acute respiratory failure each year in the United States, and survivors are often dependent on family caregivers due to severe, persistent health problems and complex medical needs following hospital discharge. Both acute respiratory failure survivors and their caregivers describe inadequate post-discharge support as a major barrier to patient recovery, and emerging evidence suggests that a family-centered intervention approach designed to meet the support needs of both patient and caregiver holds promise for improving long-term outcomes for acute respiratory failure survivors. This mentored patient-oriented research career development project will adapt and test a family- centered post-discharge support intervention to improve health outcomes for survivors of acute respiratory failure, which holds major public health relevance given the increase in acute respiratory failure survivorship due to COVID-19 and other severe, prevalent respiratory viruses.